Regulatory Roles of Zinc Fluxes in Metalloprotein Occupancy and Cell Cycle Progression

PROJECT SUMMARY
This project examimes the structure, spectroscopy, function, and mechanism of metallproteins that regulate cell
cycle progresion in response to programmatic fluctuations in intracellular zinc concentration. Zinc fluxes have
recently been discovered to be key regulatory events in human physiology, including cortical neuron function,
immune response, fertilization, and insulin secretion. Despite its apparent roles in these profound physiologies,
the biochemistry of zinc action is not well understood. Little is known regarding the inorganic chemistry of
metalloproteins involved in the instructive mechanisms that mediate cellular responses to zinc fluxes, zinc
trafficking pathways, or the role of specific metalloprotein receptors in signaling events. To interpret and
eventually intervene in diseases caused by disruption of such pathways, we must first elucidate the fundamental
molecular mechanisms of zinc-dependent switching events.
While zinc has traditionally been viewed as a static cofactor involved in protein structure and enzyme catalysis,
recent studies support the idea that zinc binding sites in regulatory proteins respond to transient fluctuations in
zinc availability and are switched on and off in ways that regulate key cellular events. We will test the hypothesis
that regulatory zinc fluxes exert instructive control over the mammalian cell cycle through specific, receptor-
mediated processes. This hypothesis is based on multiple lines of evidence, including: (1) data showing
fluctuations zinc distribution at various points in the cell cycle for single cells; (2) live cell imaging demonstrating
the movement of waves of zinc; and (3) physicochemical approaches showing colocalization of zinc with specific
factors. The overarching objective of this proposal is to use biochemical and spectroscopic approaches to
understand how the influx and efflux of zinc exert control over the cell cycle. Chemicals tools to probe and control
the concentration of zinc will be created to further our understanding of zinc physiology. In addition, we will
leverage emerging techniques in X-ray absorption and emission spectroscopy, NMR, and mass spectrometry to
understand the chemical environment of zinc and probe the zinc occupancy of zinc-containing proteins that
regulate cell cycle progression. Taken together, the results from these studies will elucidate a robust role for zinc
signaling fluxes during the cell cycle.

Public health relevance
PROJECT NARRATIVE This proposal focuses on the structure and function of metal ion receptors that translate fluctuations in zinc concentration into changes in cellular processes. These metalloprotein studies will characterize the fundamental zinc-receptor proteins that control cell cycle progression. This proposal will also develop emerging physiochemical methods and new chemical probes to characterize the zinc fluxes that ultimately govern cellular growth and division.